Isothermal Titration Calorimeter

Project Summary
A group of NIH supported investigators requests funding to purchase an isothermal titration calorimeter (ITC).
The instrument will be used to probe the thermodynamics of protein and nucleic acid complexes involved in a
number of important biological processes and diseases, including among others: microRNA biogenesis,
embryogenesis, bacterial pathogenesis, amyloid formation, Alzheimer's disease, neurobiology, cancer and gene
expression. The microcalorimeter will be located in the UCLA Biochemistry Instrumentation Facility where it will
be accessible to the entire UCLA research community. This unique technology is a label-free, rapid and reliable
means to obtain thermodynamic information about complex formation. The information obtained includes the
binding stoichiometry, affinity, enthalpy and entropy. Access to this technology is lacking at UCLA as the campus
contains only a single older-generation microcalorimeter that is no longer supported by its manufacturer and
increasing inoperable because of its age. The specific instrument we are requesting is an MicroCal PEAQ-ITC
produced by Malvern Panalytical Inc. (Westborough, MA). It represents the state-of-the-art in ITC technology
and has unparalleled sensitivity. The instrument is also capable of measuring a broad range of interactions with
micromolar to nanomolar dissociation constants. Thus, it is well suited to serve the needs of the broad user
community at UCLA. An experienced Ph.D.-level staff member with salary support from UCLA will be responsible
for operating and maintaining the instrument. UCLA will also provide funds to service the instrument, which
combined with an effective recharge system, will ensure that the microcalorimeter is productively used.

Public health relevance
Project Narrative Interactions between molecules are the basic building blocks that construct biological systems. Tools used to characterize these interactions are thus essential for life science and drug development research. This grant application requests funds to purchase a modern isothermal titration calorimeter, which can be used to elucidate the energetics of molecular interactions.